PATHOPHYSIOLOGY OF SEXUAL DIFFERENTIATION

Characterize hormonal levels and responses to stimuli including hCG to determine if hormonal abnormalities were responsible for abnormal sexual development. Categorize and define etiologies based on hormonal indices.